Microscopy and Tissue Processing Core

SUMMARY – MICROSCOPY AND TISSUE PROCESSING CORE
The Microscopy and Tissue Processing Core provides the equipment, expertise, supplies and technical service
to meet both the routine and advanced microscopy needs of NEI-funded investigators at UC Davis who
emphasize cell biological approaches. Expensive devices such as cryostats, ultramicrotomes, ventilated
embedding ovens, refrigerated UV polymerization units for catalyzing the polymerization of resins such as LR
White, and freeze substitution systems, and hazardous reagents such as the heavy metal salts for EM and
solvents and stains for LM, are all provided in a more cost-effective manner with a Core service. As many of
these reagents and processes involve hazardous compounds, it is similarly more cost effective to have
hazardous waste processing confined to a single unit. While most investigators are expert in the most
sophisticated types of light microscopy, very few have the knowledge to conduct light and electron microscopy
of embedded specimens. Having a single, well-trained staff person produces better results in a more efficient
manner.